CEIRR: CORONAVIRUS RESEARCH ACTIVITIES

CEIRR will determine the molecular, ecologic and/or environmental factors that influence the evolution, emergence, transmission and pathogenicity of respiratory viruses, including coronaviruses, and characterize the immune response to infection to improve understanding of the immune correlates of protection and cross-protection. CEIRR will carry out a host of activities, including cohort studies and human and animal sampling to further understanding of infection, transmission and vaccination; identification of immunological factors that determine disease outcome in the response to infection and vaccination; and studies to determine how viruses evolve, adapt and transmit between humans and at interspecies interfaces.

Public health relevance
Public Health Relevance: Specific Aims: